Microbial-derived factors regulating mucosal wound healing

PROJECT SUMMARY/ABSTRACT
Inflammatory bowel disease (IBD) currently afflicts more than 3.1 million people in the U.S. with over 100,000
new cases each year. Patients with IBD experience persistent and relapsing gastrointestinal tract inflammation
causing abdominal pain, bleeding, diarrhea, and weight loss. The etiology of IBD, while unknown, centers around
the loss of intestinal barrier integrity, and comprises both genetic and environmental factors, with emerging
significance of shifts in the gut microbiota. Intestinal epithelial cells (IECs) form the dynamic barrier isolating the
host immune system from the external environment. Rapid wound healing after the repeated damage and barrier
disruption seen in IBD is crucial to inflammatory resolution. An established role of the microbiota is production of
energy in the form short-chain fatty acids (SCFAs), such as butyrate. Decreases in butyrate-producing species
are strongly associated with IBD. Preliminary studies show that butyrate augments barrier formation and
enhances epithelial wound healing following injury. An unbiased single cell sequencing screen revealed that
butyrate induces IEC expression of synaptopodin (SYNPO), an actin-associated protein previously
uncharacterized in the intestinal epithelium. This proposal will test the hypothesis that the microbial-derived
SCFA butyrate promotes intestinal wound healing and barrier through coordination of SYNPO expression and
function in the context of inflammation resolution as well as homeostatic maintenance. Three specific aims will
guide this project. Aim 1 will define the mechanisms of SYNPO regulation by SCFAs, including butyrate, through
cell culture and promoter reporter analysis. Aim 2 will elucidate the functional role of SYNPO in IECs utilizing
knockdown and overexpression cells and immunofluorescence. Aim 3 will determine the contribution of SYNPO
in health and during mucosal disease using murine colitis models. Successful completion of this work will
establish a critical role for the microbiota in regulating wound healing and ultimately recovery from IBD through
a novel target, SYNPO. Understanding the mechanisms through which butyrate repairs tissue damage and
restores the intestinal barrier will contribute to current therapeutic approaches.
This comprehensive research training plan will provide outstanding mentorship with an experienced sponsor
in the ideal environment of a rigorous basic science lab that is well-integrated clinically with the necessary
resources for completing each aspect of this project. This includes a distinct mentorship team within the Mucosal
Inflammation Program in addition to the guidance of the applicant’s thesis committee. This training will foster the
applicant’s research and academic skills to pursue cross-cutting molecular level science that will advance
therapeutics for tissue damage repair and novel disease target identification. These mechanistic studies hold
translational potential to improve the quality of life for IBD patients and provide the optimal progression towards
a career balancing biomedical research and clinical practice as a physician scientist.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel disease (IBD), debilitating conditions often requiring a lifetime of costly care, afflicts more than 3.1 million people in the U.S. and is characterized by chronic and relapsing inflammation that damages the intestinal mucosal surface and reduces barrier function. Colonic bacteria produce important sources of energy for epithelial cells in the form of short-chain fatty acids such as butyrate through fermentation of undigested material, and a selective decrease of butyrate-producing microbes is linked to IBD. This proposal will examine how microbial-derived metabolites, such as butyrate, promotes tissue damage repair through regulation of a novel target, actin-associated protein synaptopodin, contributing new insight into disease process and recovery to ultimately advance therapeutic options for IBD.